LJI Epitope Validation Center: Characterization of epitope-specific T cells responding to food, fungal and inner city allergens

CENTER PROGRAM SUMMARY/ABSTRACT
Our proposal will use epitopes to comparatively evaluate immune responses in three different prototypic
allergic diseases. We will study cockroach (CR) and mouse (MO) inhalation allergens, which are associated
with the development of asthma in inner city children (Project 1); cow’s milk (CM), the most prevalently
recognized pediatric food allergen (Project 2); and Aspergillus (ASP) and Alternaria (ALT) fungal allergens,
which are associated with severe forms of asthma (Project 3). The extensive scientific overlap will offer
opportunities for synergies between projects. Our study extensively utilizes cohorts independently funded by
NIAID, to further multiply synergies and impact of the investigations. The evolution of responses will be
examined as a function of time following natural exposure, exposure as part of work-duties and allergen
immunotherapy (AIT). We will also study and compare individuals that are exposed but remain healthy, to
people that have mild allergies and those that have severe asthma. Our hypothesis is that these distinct groups
can be distinguished on the basis of their T cell response. Specifically, different groups might recognize
different protein allergens or fragments (epitopes). It is also possible that the protein and genetic programs
characteristic of T cells (T cell phenotypes) seen in allergic diseases of different types and severity will be
unique. Our additional hypotheses are that evolution of T cell phenotypes can give us insights into the
mechanism of allergic and asthmatic disease. If this were to be the case, it would have potential diagnostic
value, and possibly suggest new therapeutic interventions.

Public health relevance
OVERALL PROJECT NARRATIVE T cell responses are a key component of allergic disease and definition of the actual epitope fragments derived from allergens and recognized from T cells allows accurate measurement, quantification and isolation of allergen-specific T cells. Our proposed research targets several important allergen systems: cockroach and mouse allergens because they correlate with asthma development in inner city, food allergens that are an important source of pediatric disease, and fungal allergens, whose recognition correlate with severe asthma. Definition of the exact features of these T cells will allow comparison of their molecular programs with the severity and evolution of clinical disease, and potentially suggest new diagnostic and therapeutic approaches.